A patient-centered approach to urinary incontinence in adults with spina bifida

Spina bifida (SB) is a disease requiring life-long urological care, particularly for urinary incontinence (UI), a
challenge for most children, adolescents and adults with SB. As people with SB age, UI becomes enmeshed in
an ever more complex context. This includes changing levels of independence, family and social support,
romantic and sexual experiences, as well as education and employment opportunities, all combined with
previous behavioral, medical and surgical UI treatments. A patient-centered approach allows these often
overlapping, and sometimes competing, concerns to be better evaluated and managed. Unfortunately, no tool
exists to assist SB adults to weigh UI in the context of other concerns, to decide whether UI impact on their
lives warrants treatment, and/or to help them select treatment goals meaningful to them (and not just to their
family or health-care team). The work outlined in this R03 proposal will build on my K23 award (K23
DK113227) where I developed the MyGoal-C app, a tool to help SB children identify interest in treating UI and
establish their own continence goals. For this R03 award, I propose to build a similar tool (i.e., MyGoal-A app)
targeting disabled adults with SB. One factor that will set the adult app apart from the MyGoal-C app is its lack
of a parental component. Additionally, SB adults will have more specific and personalized UI treatment goals
related to work, sexuality, and comorbid conditions to be integrated in the MyGoal-A app. An adult-focused app
should allow more effective shared decision making (SDM) between adult patients and their clinicians by
helping patients identify health outcomes of highest priority, and then to work with their clinicians to determine
treatments most likely to achieve them. I anticipate that the MyGoal-A app will have significant impact on adult
SB care, and I hypothesize that this will lead to improved health-related quality of life (HRQOL) for these
patients. The specific aims for the R03 proposal are to: (1) Engage adults with SB to better understand their UI
experiences in the context of other competing care issues, and (2) Employ a mixed-methods approach to a)
adapt the MyGoal-C app for use with SB adults and b) perform usability testing of the MyGoal-A app. In Aim 1,
we will use online questionnaires with 20 SB adults recruited online through patient advocacy groups to detail
patient experiences and priorities for continence. Building on Aim 1, we will develop the MyGoal-A app using
the MyGoal-C app from my K23 award as a starting point. Using a qualitative research approach that
integrates design thinking methods, both patients (N=20) and urology providers (N=8) will be involved in the
creation and refinement of the MyGoal-A app prototype (Aim 2a). We will then conduct two rounds of usability
testing with SB adults (N=20) using a mixed-methods approach (Aim 2b). The work of Aim 2 will culminate in a
finalized MyGoal-A app ready for real-world testing. The research with SB adults from this R03 proposal will
lead to a R01-level application for a prospective randomized controlled trial of the MyGoal-A app in SB adults,
focused on goal selection, goal attainment, UI changes, SDM, patient-provider communication and HRQOL.

Public health relevance
Project Narrative Spina bifida (SB), the number one congenital central nervous anomaly, causes urinary incontinence (UI). Managing UI in SB adults is challenging since UI is not their only concern. Focusing on patient experience, we will develop an app, giving SB adults a voice in choosing UI treatment goals, allowing for a future study of UI and quality of life.